Mentored Patient-Oriented Research in Natriuretic Peptide System Based Precision Cardiometabolic Health

PROJECT SUMMARY
Dr. Pankaj Arora is an Associate Professor of Medicine (Tenured), the Director of the Cardiovascular Genomics
Clinic, and the Director of the Clinical and Translational Research Program at the University of Alabama at
Birmingham (UAB). His ultimate career goal is to establish a Center for Precision Medicine that will provide
multidimensional training incorporating clinical epidemiology, big data analysis, designing and conducting clinical
trials, genomic studies, and precision medicine to young trainees to develop them into well-rounded physician-
scientists. He has established a successful, federally-funded (3 R01 awards) laboratory that focuses on
assessing the genetic determinants of natriuretic peptide (NP) levels, unraveling the pathophysiological
pathways through which NPs cause cardiometabolic disease, and developing targeted approaches centered on
the NP system to treat cardiometabolic diseases. Apart from NP-based projects, his research team has a
consistent output of mentee-led projects ranging from epidemiological studies on cardiovascular health to the
disparities in clinical outcomes in cardiovascular diseases, which have been published in prestigious journals.
Dr. Arora has trained >20 mentees at various career stages, including undergraduate students, medical students,
residents, cardiology fellows, and T32 fellows. The K24 award will provide Dr. Arora with protected time to
mentor trainees and develop individualized plans to help his mentees achieve their research career goals. He
would also work on improving his mentorship skills through the experiences of his mentorship team, comprised
of previous K24 awardees with decades of mentorship experience, and through formal didactics on mentorship
offered by the UAB Center Clinical and Translational Science. Furthermore, he will expand his research focus
to include advanced genomics, proteomics, and implementation science. Dr. Arora will learn specialized genetic
analytic techniques (rare and structural variant analyses) and gain hands-on experience in conducting targeted
mass spectrometry to study the bioactive levels of NPs. Recognizing the challenges of implementing the results
of research in clinical practice, Dr. Arora will attend didactics and work with an implementation scientist to devise
a plan for the clinical implementation of polygenic risk scores in the Cardiogenomics Clinic. Dr. Arora proposes
3 unique projects that cover the range of clinical research including a post-hoc analysis of an ongoing R01 study
to assess the racial differences in response to NP augmentation on correcting a non-dipping BP profile, examine
the bioactive levels of NPs and their response to physiological perturbations using blood samples collected in 2
R01 studies, and determining the contribution of genomics to NP levels using data from a multi-ethnic cohort of
US individuals. Therefore, these projects would not only expand the current knowledge on NPs and their role in
cardiometabolic disease but also provide mentees with unparalleled training in clinical research.

Public health relevance
PROJECT NARRATIVE Natriuretic peptide deficiency may play a causal role in the development of cardiometabolic diseases and in turn increase the risk of cardiovascular disease. Establishing a patient-oriented research program integrating precision medicine and genetics will train investigators capable of uncovering the mechanistic pathways through which natriuretic peptide deficiency leads to cardiometabolic disease and develop individualized treatment strategies to alleviate the rising burden of cardiometabolic disease. This award will provide protected time to Dr. Arora, a successful mid-career investigator, to mentor young trainees to develop them into well-rounded clinical investigators of the future and add new research skills to his portfolio.